Expanded evaluation of the role of antibody-dependent innate effector function in TB disease progression in HIV co-infected individuals

PROJECT SUMMARY/ABSTRACT
HIV is the most important risk factor for progression to active tuberculosis (TB), but the immunologic
mechanisms for this increased rate of progression are incompletely defined. Antibodies serve an important role
coordinating the innate and adaptive immune compartments through the Fc-domain of the immunoglobulin
molecule. Antibody production and Fc features are known to be broadly dysregulated in HIV infected individuals.
This proposal will test the hypothesis that perturbations to antibody Fc-mediated functions contribute to increased
risk in HIV infected individuals.
This proposal presents a five-year research career development program to comprehensively investigate
the roles of antibody-dependent effector functions in TB progression in the setting of HIV coinfection. Prior data
indicate antibodies can predict TB progression in HIV-negative individuals and can confer protection against Mtb
infection in vitro. Preliminary data presented here indicates that Ab functional features, and specifically
neutrophil-activating functions, are altered in HIV co-infection. Published data suggest that neutrophils can play
both pathogenic roles in TB (such as NETosis) and putatively protective roles (such as phagocytosis). In the
studies proposed here, we aim to 1) apply expanded effector functional profiling to evaluate the impact of HIV
on the breadth of Fc-mediated effector functions, and 2) define the antibody-dependent functional correlates that
predict TB progression and Mtb antimicrobial control in the setting of HIV co-infection. We will leverage human
plasma samples from two unique international cohorts: for Aim 1, we will use a Ugandan cohort of individuals
with latent TB infection to investigate the impact of HIV on Mtb-specific antibody functionality; for Aim 2, we will
use a multinational longitudinal cohort of HIV-coinfected TB progressors to evaluate both cross-sectional and
temporal differences in Fc-mediated effector function. We will use innovative experimental and analytic
methodologies including a high-throughput systems serology platform, in vitro functional assays measuring the
ability of antibodies to drive NK cell activation, monocyte phagocytosis, complement deposition, and an
expanded suite of neutrophil functions, and validated in vitro antimicrobial growth restriction assays.
The candidate is currently an Instructor in Medicine at Brigham and Women’s Hospital with an ongoing
research commitment of 75% time. The proposal is supported by an expert mentor in TB immunology and
mycobacteriology, Dr. Sarah Fortune at the Harvard School of Public Health. The training plan unites the
candidate’s postdoctoral training in humoral immunology with specific training in innate immunity, TB
immunology, TB pathobiology, and bioinformatics, as well as ongoing professional development coursework.
Completion of this comprehensive training plan will ensure the candidate’s successful development of a unique
independent translational research program focused on Fc effector functions and systems immunology.

Public health relevance
Narrative HIV co-infection is the leading risk factor for development of active tuberculosis (TB), yet the mechanisms underlying increased rates of progression are not fully understood. The proposed research dissects the impact of HIV on the induction of antibody-dependent innate effector functions and identifies key functional correlates of TB disease progression and control in HIV- coinfected individuals. The results will provide mechanistic insights into antibody-mediated immunomodulation, and inform the development of novel diagnostics, therapeutics, and vaccines to specifically address divergent TB pathogenesis in people living with HIV.